TOXICOLOGY CONSULTING FOR REPRODUCTIVE SCIENCE and Contraception Research

NICHD supports a broad range of contraceptive research, including efforts to develop new contraceptives for women and men.
This contract is to provide support for ad hoc consulting and opinions services on reproductive toxicology for the Contraception Research Branch (CRB) of NICHD. The awarded contract will support CRB’s contraceptive research through knowledge and experience in rigorous design and conduct of reproductive pharmacology and toxicology and related studies.